Path C Maintaining the Produce Safety Rule in Mississippi to Enhance Safety in Growing, Harvesting, Packing, and Storing Fresh Fruits & Vegetables MDAC

Project Abstract Summary
This Mississippi Department of Agriculture and Commerce’s (MDAC) project intitled Maintaining
the Produce Safety Rule in Mississippi to Enhance Safety in Growing, Harvesting, Packing and
Storing Fresh Fruits and vegetables seeks to continue the implementation of the Food Safety
Modernization Act’s Produce Safety Rule. MDAC is seeking funding support for personnel,
travel, training, equipment, and supply costs needed to continue implementing its
comprehensive and integrated produce safety division. To continue its alignment with the
Produce Safety Rule, MDAC will require comprehensive assessments and new levels of
cooperation between our state’s land grant universities, Mississippi State University and Alcorn
State University. The activities that must take place to continue this alignment will not occur
without significant and sustained financial obligations. The outcome of these activities will
continue the development of multi-faceted administrative program(s) in support of the Produce
Safety Rule. To date, the Mississippi State Legislature has not obligated monies for the
development of a Produce Safety Division within the MDAC, and the goals set forth in this
application will not be achieved without funding secured through a Cooperative Agreement with
the U.S. Food and Drug Administration. To align itself with reaching the goals of the Produce
Safety Rule, the MDAC Regulatory Services Bureau has created a new Produce Safety Division
through the funding provided by competition A and B. The Produce Safety manager has been
hired to oversee one Outreach Coordinator, and possibly two Outreach Specialists, and work
directly as the liaison with other agencies and universities to accomplish the goals of the project.
One Produce Regulatory Supervisor and one Produce Regulatory Inspector has been hired and
plan to hire additional Regulatory inspectors. This successful implementation of the Produce
Safety Division allows the Produce Safety Manager to manage all programmatic activities
included but not limited to the development of a Strategic Action Plan, stakeholder
communications, educational outreach to industry, audit assistance, enforcement support, and
the development of the Mississippi Farm Inventory. The Produce Safety Division anticipates
identifying 2,066 covered farms in the state, educating 1,595 covered farms, and inspecting 47
farms annually by July 1, 2026. The Mississippi Department of Agriculture and Commerce’s
Produce Safety Division is a Path C Program. 69-1-56 Mississippi code of 1972 adopts the
FDA’s Produce Safety Rule (21 CFR Part 112) in its entirety.

Public health relevance
Project Narrative This Mississippi Department of Agriculture and Commerce’s (MDAC) project entitled Maintaining the Produce Safety Rule in Mississippi to Enhance Safety in Growing, Harvesting, Packing, and Storing Fresh Fruits and Vegetables is intended to sustain the established produce safety program that encourages the safe production of fruits and vegetables and promotes understanding and compliance with FDA’s Produce Safety Rule. To sustain the established produce safety program, MDAC will: • Continue to assess and identify the produce landscape and available resources in Mississippi • Continue to leverage current resources and invest in the infrastructure needed for appropriate outreach, education, and technical assistance to produce growers • Continue the development of the established inventory of farms in Mississippi • Promulgate regulations based on the Mississippi produce safety law • Continue and sustain the established compliance program for the Produce Safety Rule These five goals will greatly advance a national Integrated Food Safety System (IFSS) and effectively fulfill the requirements of the Food Safety Modernization Act (FSMA).